Microbial Metabolites Inhibiting Salmonella Carriage and Disease

ABSTRACT
Diffusible signal factors (DSFs), long-chain fatty acids with a characteristic cis-2 unsaturation, are produced
and used by several genera of gram-negative bacteria as quorum-sensing signals. We have found that the
DSF cis-2 hexadecenoic acid (c2-HDA) is extremely potent in inhibiting expression of Salmonella functions
necessary for colonization of the intestine and have found this compound to be present in the murine large
intestine. As no mammalian source of fatty acids harboring a 2-cis unsaturation has been described, these
findings strongly suggest that constituents of the gut microbiota produce and excrete DSFs that inhibit
Salmonella virulence. We hypothesize that Salmonella uses the signals of these bacteria to balance its
virulence functions, essential but also costly to the fitness and survival of the invading bacteria, with
colonization and proliferation of the Salmonella population. Gut microbial metabolites may therefore serve
multiple coordinated purposes in pathogens, balancing virulence functions with those required for proliferation
within a host and thus affecting pathogen survival in the gut by multiple means. Here we propose to: Aim 1:
Use complementary approaches to identify bacteria of the human gut microbiome that produce inhibitory DSFs
and characterize their products; Aim 2: Identify the constellation of functions regulated in Salmonella by DSFs
and identify mechanisms of this control, and; Aim 3: Using established murine models of Salmonella infection,
characterize the biological function and translational relevance of c2-HDA to understand its mechanism of
action and to support the eventual development of novel therapeutics, such as live biotherapeutic products, for
the control of human salmonellosis.

Public health relevance
PROJECT NARRATIVE We have identified a class of microbial metabolites, present within the intestine, that potently represses functions of Salmonella required for this pathogen to colonize and cause disease. We aim to identify the bacterial sources of these signals within the gut microbiome and to characterize their global effects on Salmonella virulence functions. This work is innovative and impactful as it investigates a novel means to reduce the public health threat of salmonellosis.